UC Irvine AD Translational Center for Disease Model Resources-NextSeq Supplement

Project Summary/Abstract A key goal of the UCI Model-AD Disease Model Development and Phenotyping Project (DMDPP) is to characterize the gene expression levels of the new rodent models of sporadic AD being generated by the consortium during aging. This involves the building of numerous bulk and single-cell RNA-seq libraries for Model- AD mice. All of these libraries are currently sequenced on an Illumina NextSeq 500 purchased in 2013. As this instrument is nearing its end-of-life support by Illumina, we are requesting funds to upgrade the Illumina NextSeq 2000 system in order to increase the reliability and throughput of sequencing the bulk and single-cell RNA-seq libraries produced by UCI Model-AD. The upgrade will ensure the timely sequencing of the RNA-seq libraries for the characterization of the changes of gene expression during aging in the UCI model-AD rodent models.

Public health relevance
Project Narrative This supplemental request is for funds to upgrade of an IIlumina NextSeq 2000 in order to increase the throughput and reliability of sequencing bulk and single-cell RNA-seq libraries for the gene expression phenotyping of the new rodent models of Alzheimer’s disease created by MODEL-AD.